Optimizing residential treatment gains for adolescents through tailored behavioral parent training

Project Summary
Although adolescents (ages 11 to 17) make treatment gains (e.g., reduced internalizing or externalizing
behaviors) in psychiatric residential treatment (RT), they experience significant difficulty adapting to the
community and often do not sustain treatment gains long term. After RT, 70% of adolescents discharge to their
family of origin. However, parents are not provided with the necessary support or behavior management
skillset to bridge the gap between RT and home. A new federal mandate will soon require parent training, an
evidence-based behavior management intervention, in the RT setting. Parents with adolescents admitted to RT
are a difficult-to-reach population, and technology may increase access and uptake of parent training.
Parenting Wisely (PW) is a web-based parent training with demonstrated efficacy in increasing effective
parenting practices to reduce adolescent behavior problems. We previously found that PW was highly feasible
for parents and the skills were perceived as useful. However, parents reported two unmet needs: (1) skill
individualization to apply the PW skills and (2) enhanced community to reduce isolation. In collaboration with
an advisory board (a partner in the proposed study), we augmented PW with clinician facilitated discussion
groups (referred to as PWRT). The discussion groups in PWRT supports program completion and parent
engagement, provides a venue to discuss individualizing PW strategies, reduces isolation, and support parents
by engaging in conversation about parenting in the RT context. The proposed study aims to: (1) establish
feasibility and acceptability of PWRT, (2) evaluate whether PWRT engages target mechanisms (parental self-
efficacy, parenting behaviors, social support, family function), and (3) determine the effects of PWRT on
adolescent outcomes (internalizing and externalizing behaviors, placement restrictiveness). Sixty parents (30
per condition) will be randomly assigned to PWRT or treatment-as-usual (TAU). Each week for six weeks,
parents will complete two PW modules (20 minutes each) and attend one discussion group via Zoom (90-
minutes). PWRT will be initiated towards the end of the RT admission and continue post-discharge to bridge the
transition from RT to the community. Adolescents (n=60) will not receive intervention; however, we will
evaluate the feasibility of adolescent data collection for future studies. Data from parents and adolescents will
be collected at baseline, 6-weeks, and 6-months post-baseline to allow for a robust understanding of the
longer-term effects of PWRT on treatment gain maintenance. Consistent with PAR-21-211, our team of
researchers and community partners is collecting the requisite data for a larger-scale effectiveness trial by
testing the feasibility, acceptability, and preliminary effects of PWRT vs. TAU. PWRT is among the first web-
based parent training augmented with supportive elements designed to engage parents with adolescents in
RT. By providing parents with tailored education and support in PWRT, parents will be equipped with the
behavior management skillset to provide structure in the home and ultimately maintain RT treatment gains.

Public health relevance
Project Narrative Residential treatment is the most restrictive, intensive, and costly setting available for adolescents with severe emotional and behavioral healthcare needs; yet, 78% of adolescents do not sustain treatment gains once they transition to the home environment. This study aims to promote treatment gain maintenance by testing a web- based parent training augmented with virtual clinician facilitated discussion groups (referred to as PWRT) to prepare parents for the reintegration of their adolescents in the home. PWRT has been specifically designed to meet the needs of parents, adolescents, and residential treatment facilities by moving intervention outside of traditional delivery settings and into the home, increasing parent engagement, access to care, and sustaining residential treatment gains.